Collaboration and Service Projects p. 170

Project Summary The Collaboration and Service efforts at the National Center for the Quantitative Biology of Complex Systems (NCQBCS) will be focused on the dissemination of expertise and knowledge to researchers across the country, establishing a strong foothold for our developed technologies throughout the nation. A core mission of the NCQBCS is to provide broad access to proteomic technologies, facilitating the advancement of biomedical research programs at institutions that lack the skills and/or resources necessary to conduct proteomic experiments. Our Center's effective blend of technological expertise and state-of-the-art instrumentation makes us well-suited and excited to work with these outside investigators towards a unified goal. Having formed and managed numerous productive and successful collaborations in the past, we look forward to establishing the NCQBCS as a valuable resource that will provide Collaboration and Service opportunities to the biomedical research community.